Partnering with an Urban Safety Net Hospital to Deliver Stroke Preparedness in the Emergency Department

Abstract
Acute stroke treatments are time-sensitive. Tissue plasminogen activator is administered 3 to 4.5 hours from
the time of freedom from stroke symptoms. Imaging technologies such as computed tomography perfusion
might extend the treatment window. However, rapid hospital arrival remains critical to eligibility for stroke
treatment that can reduce subsequent disability. African Americans are more likely than Whites to delay in
hospital arrival after stroke symptom onset. Prior interventions have educated African American groups or the
entire community about stroke and the importance of calling 911. One-on-one stroke education interventions
are few in number. This project aims to educate African Americans individually when they present to the
emergency department (ED) of an urban safety net hospital. This approach allows us to access a hard-to
reach population at high risk for stroke to deliver a one-on-one stroke intervention that addresses specific
reasons African Americans delay in hospital arrival. By directly engaging with each participant, we expect to
improve attitudes towards calling 911, which promotes early hospital arrival, and eligibility for stroke treatments
which can ultimately reduce the burden of stroke on the population. Our specific aims are (i) to adapt a group-
based stroke education intervention to be delivered in a one-on-one format to patients presenting to the ED,
through qualitative interviews of patients and providers, (ii) to test whether the stroke intervention improves
behavioral intent to call 911, as measured by response to stroke and non-stroke video vignettes. This research
is in line with my career goal of developing, testing, and implementing behavioral interventions that will reduce
racial disparities in stroke incidence and treatment. To this end, my plan is to (i) obtain skills in the practical
application of community based participatory research, a research approach which involves partnering with the
community to develop behavioral interventions, (ii) build skills in randomized clinical trial design, as rigorous
efficacy testing of behavioral interventions involves randomization of participants, (iii) building expertise in
implementation science methods, so that I can translate the interventions that I develop into clinical practice.
The mentorship and resources at the University of Michigan will enable me to accomplish these career
development goals. At the University of Michigan, I am among a group of accomplished health equity stroke
researchers who have a track record of obtaining R-level NIH funding and are making significant contributions
to reducing the burden of stroke on society. The university facilitates interdepartmental research collaborations,
enabling me to be mentored by established researchers within and outside of the department of neurology.
Courses are taught by experts in their field, providing a rich learning environment. Additional resources include
organizations that offer seminars and workshops to facilitate the transition to an independent investigator. The
proposed project and career development plan will expedite my research independence. Future R01 studies
will involve scaling up and implementation of the proposed intervention.

Public health relevance
Project narrative Delay to hospital presentation after stroke symptom onset prevents African American patients from being eligible for stroke treatments that reduce disability. Previous educational interventions designed to educate African American patients about stroke and the importance of calling 911 have mostly been delivered community-wide or in a group format, settings that do not adequately address individual reasons for hospital delay. This project will determine whether delivering stroke education individually to African Americans at high risk for stroke improves recognition of stroke symptoms and intent to call 911 if stroke symptoms should occur.